Time-Variant Effects of Cancer Risk Factors in Nested Case-Control Studies

DESCRIPTION (provided by applicant): In many cancer epidemiology cohort studies, the disease of interest is often rare but the study hypothesis is complex with a large number of risk factors. These studies usually require a long-term follow-up to obtain an adequate number of cancer events and to elucidate the course of the disease. Therefore, it can be prohibitively expensive to assemble data for the entire cohort. Nested case-control (NCC) design is a popular sampling method prominently due to its cost-effectiveness. In practice, NCC data are commonly analyzed using Cox's proportional hazards (PH) model. A direct consequence of the PH model is that the ratio of hazard functions with different covariate values is assumed to remain constant over the entire follow-up period. Due to the nature of long-term observation and complexity of the relationship to be explored in large-scale cancer studies, the proportional hazards assumption may easily be violated. Therefore, extensions of Cox's model to accommodate time-varying covariate effects not only are necessary to improve the modeling 0exibility but also are critical to elucidate the etiology of cancer. However, methodology developments for such 0exible models have been mainly focused on cohort studies and their uses in NCC studies remain limited. In this project, we propose to study the Cox model with time-varying coe1cients to characterize temporal effects of cancer risk factors in NCC studies. In Aim 1, we propose to develop statistical methodologies to estimate the time-varying coe1cient functions using a kernel-weighted partial likelihood approach;to construct point-wise and simultaneous confidence intervals of the estimated time-varying coe1cients;to test and identify the existence of time-varying effect of specific risk factor;and to investigate the variable selection problem in the Cox model with time-varying coe1cients for NCC data. Once the asymptotic properties of the proposed method are established in theory and the inference procedures are validated using extensive Monte Carlo simulation studies, we can implement our proposed approaches to pursue Aim 2, which will focus on real data analyses and software development. The first part of Aim 2 will be accomplished through collaborations with the New York University Women Health Study (NYUWHS). Then developing and contributing an open-source R package will make the proposed methodologies freely available to practical researchers. Successful completion of the proposed studies will provide a series of advanced statistical inference approaches to elucidating the temporal effects of risk factors on the cancer development for NCC studies, which will also substantially improve our modeling 0exibility in the analysis of NCC data, and can assess and validate the results obtained from other methods. Furthermore, the application in NYUWHS will provide us new insights and better understanding on the effects of potential risk factors in cancer etiology. The fund mental contribution of development of freely-available software package is that it will translate the advanced statistical methodologies into practically useful and accessible tools. PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE: Nested case-control design, a cost-effective sampling method commonly used in cancer epidemiologic studies, necessitates developing 0exible statistical approaches to evaluate the association between cancer and risk factors. This research project proposes to develop statistical models and inference approaches to accommodating and characterizing temporal effects of cancer risk factors for NCC studies, to provide new aspects and novel insights into the temporal relation between disease and its risk factors, and to elucidate our understanding of cancer etiology. Furthermore, contributing freely available software is essential to equip practical investigators with alternative tools to analyze NCC data and to assess, compare and validate study results.

Public health relevance
PROJECT NARRATIVE: Nested case-control design, a cost-e(R)ective sampling method commonly used in cancer epidemiologic studies, necessitates developing ﬂexible statistical approaches to evaluate the association between cancer and risk fac- tors. This research project proposes to develop statistical models and inference approaches to accommodating and characterizing temporal e(R)ects of cancer risk factors for NCC studies, to provide new aspects and novel insights into the temporal relation between disease and its risk factors, and to elucidate our understanding of cancer etiology. Furthermore, contributing freely available software is essential to equip practical investigators with alternative tools to analyze NCC data and to assess, compare and validate study results.